Function and regulation of epithelial glycosylation

Summary/abstract
This research program focuses on uncovering the biological roles of glycoconjugates. Part of this effort is
devoted to the development of chemical biology tools for glycoscience research. Using one of these
photocrosslinking sugars, we made the unexpected observation that cholera toxin can bind fucosylated
glycoconjugates in addition to its canonical receptor, the ganglioside GM1. One of the goals of the parent award
is to determine the molecular structure of fucosylated glycoconjugates recognized by cholera toxin and
characterize their role in host cell intoxication. The long-term goal of these studies is to determine how glycan
features vary among individuals and their association with disease states. Ms. Sanchez will extend these studies
by investigating the mechanism by which ABO blood group type affects host cell intoxication by cholera toxin.
Her studies will take advantage of key reagents and techniques in place in the Kohler lab and will explicitly
interrogate the roles of glycoprotein and glycolipid receptors for cholera toxin. She will also examine the
closely-related E. coli heat-labile, which exhibits distinct glycan binding specificities that have not been defined
in a cellular setting. Throughout the funding period, Ms. Sanchez will engage in educational and training
activities designed to prepare her for a in biomedical research. Ms. Sanchez's training program is personalized
to her interests, strengths, weaknesses, and long-term career goals. Areas of focus include critical evaluation of
the scientific literature, navigating the peer review process, honing presentation style, developing time
management skills, investigating career opportunities in bio-entrepreneurship, and outreach to groups
underrepresented in biomedical science.

Public health relevance
This application requests funding to support the graduate training of Jennifer Sanchez, a first-year graduate student who will be studying the glycan-binding preferences of two enteric bacterial toxins. These studies relate directly to one of the goals of the MIRA parent award: Investigate how diverse glycoconjugates function in host cell recognition by cholera toxin. Ms. Sanchez will interrogate the role of ABO blood group in the mechanism of cholera intoxication and also examine the closely related E. coli heat-labile toxin, while also receiving training in biomedical research practice and career development.